DNA Damage Response and Oncogenic Signaling

Project Summary
Increases in cancer incidence and rising cancer costs highlight the need to advance cancer biology through the
growth of a well-trained workforce. Almost all human cancers have alterations in signaling pathways associated
with DNA damage response and oncogenic signaling, and such pathways are also the focus of targeted therapies
already in the clinic and under development. To train the next generation of cancer researchers, we have
developed an institution-wide cancer biology training program for postdoctoral fellows focused on this area of
cancer research, called the DNADRS program. This program is housed at the City of Hope, an NCI-designated
Comprehensive Cancer Center, which is known internationally for clinical cancer research and has an
outstanding record of basic cancer research. This T32 program began in 2016, and this is the first renewal
application. The 3 T32-supported postdoctoral trainees supported for up to 3 years are selected for the DNADRS
program through a rigorous process, including a personal interview. Each trainee establishes a mentoring
committee that includes a physician to foster cross-pollination of ideas between the basic and translational
aspects of cancer research. Annual reappointment is based on annual written reports from the trainee and
mentoring committee. As part of a recruitment incentive in the DNADRS program, City of Hope will continue to
provide an additional postdoctoral trainee position for every underrepresented minority trainee recruited, up to a
total of 6 positions. Furthermore, to attract the best postdoctoral candidates at a national level, City of Hope
continues to commit to salary supplementation for all DNADRS trainees, a stipend for research supplies, and full
administrative and faculty salary support. Trainees will be mentored by 18 faculty members, all of whom are
performing cancer-focused high-impact research and have a history of mentoring postdoctoral fellows. To
enhance their chances of developing into independent cancer researchers, all DNADRS trainees take a unique
common curriculum that provides a continuum of learning including scientific coursework that includes ethical
conduct of research and proper research design, as well as professional development courses. In addition,
trainees participate in cutting-edge research programs, journal clubs, seminars, symposiums, regular luncheons
with mentors, mentoring committee meetings, national and international scientific conferences, and finally a
yearly DNADRS Symposium. The stellar and comprehensive Shared Resource Facilities associated with the
Cancer Center provide training in state-of the art technologies. The request for funding to renew this research
training grant is justified by our track-record from the last funding cycle of seven successful trainees that include
three underrepresented minority fellows, the relevance of the research training to cancer, the experience of the
mentors, the outstanding commitment of City of Hope, and the diverse population of the geographical area
served by our institution.

Public health relevance
Project Narrative To support the development of novel anti-cancer therapies, we propose continuation of a multidisciplinary, institution-wide cancer biology T32 postdoctoral training program at City of Hope (Duarte, CA) to prepare exceptionally motivated postdoctoral fellows in the fields of DNA damage response and oncogenic signaling (DNADRS). Because cancer disproportionately impacts minority populations in the US, we have implemented a strategy, which is aided by exceptional institutional support for salaries and research funds, to emphasize attracting and training scientists from underrepresented minority (URM) backgrounds. With our collection of outstanding DNADRS researchers and physician collaborators, state of the art facilities, strong curriculum, emphasis on obtaining extramural funding, superb institutional support, and the last 5 year’s successful experience, we request the continued support to DNADRS T32 program, which will train the next generation of leaders in the fight against cancer.